An intervention to promote healthy relationships among transgender and gender expansive youth

PROJECT SUMMARY
Transgender and gender expansive (TGE) youth identify as a gender different from their sex at birth. Research
tends to define this group based on high rates of sexually transmitted infections (STIs), sexual risk behaviors,
violence exposures, and other health outcomes. Little work has used a supportive, resilience-based framework
or a human-centered approach. We conducted preliminary qualitative/co-design studies to understand sexual
health content needs and format/design preferences. Content areas recommended by TGE youth, their
families, providers, and/or advocates include: a) Youth/ providers noted that puberty can produce dysphoria for
TGE adolescents and that information/tools would be beneficial; b) Participants asked for non-judgmental
information about STI risks and prevention; c) Youth/providers asked for content around contraception that
clarifies that gender-affirming medical interventions do not prevent unintended pregnancies; d) Participants
recommended destigmatizing and normalizing diversity in sexual attractions and desires; e) TGE youth raised
disclosure of TGE identity as a unique challenge and asked for communication skills training to help them
maintain agency over when and how to disclose; and f) Participants described difficulties navigating partner
consent because it is often described in heteronormative, binary terms in sexual education classes. TGE youth
also described favoring written materials for more fact-based content on contraception and STIs, interactive
formats for content that requires personalization by gender and/or degree of medical transition, and multimedia
approaches emphasizing lived experience perspectives for information around desire, gender identity
disclosure, and consent. Participants also provided design guidance (e.g., use of a covert color palette that
would not unwantedly disclose users’ transgender status in public) and specific features (e.g., blacklisting
functions to protect the user from triggering content; robust search and filter system to easily locate information
specific to an individual’s needs). Based on these themes, we co-designed a paper intervention prototype with
TGE youth. In this proposal, we will engage a Youth Advisory Board and Community Consultants to co-design
a fully functional online interactive sexual education tool (OISET) with TGE youth (Aim 1a) and conduct
cognitive interviews to refine select survey tools and ensure gender-affirming intervention effect measurement
in a future R01 (Aim 1b). We will then conduct an unbalanced, randomized controlled pilot study with 40 youth
(30 intervention:10 control) to refine content and establish feasibility of the OISET and data collection
protocols/procedures (Aim 2). Primary outcomes will be intervention usability/feasibility/appropriateness/
acceptability and study feasibility. We will collect baseline, post-intervention, and 3 month data on knowledge;
general/sexuality-specific self-efficacy; partner communication; risky sexual behaviors; social support; and
resilience. This project is innovative, rigorous, and responsive to NICHD/NINR/SGMRO priorities. It will result
in the first evidence- and strengths-based online sexual health intervention for TGE youth.

Public health relevance
PROJECT NARRATIVE Transgender and gender expansive (TGE) youth are at high risk of several sexual health outcomes that have life-long impacts including sexually transmitted infections, early, unwanted pregnancies, and unwanted sexual contact/intimate partner violence. TGE youth deserve effective, assets-based, gender affirming sex education, but current educational and clinical structures largely ignore their experiences. We propose to use youth- engaged co-design methods to develop and pilot test an online interactive sexual education tool for TGE youth in preparation for a future randomized, controlled trial/R01.